IGF::OT::IGF FOR OTHER FUNCTIONS - PURPOSE OF MODIFICATION 8: TO ADD FUNDS FOR ERA SOFTWARE SUPPORT SERVICES IN THE AMOUNT OF $1,699,687.00.

Support provided to accelerate the development of xTRACT, specifically requirements for and to develop the capacity to transfer data from external trainee tracking systems to xTRACT.